Therapeutic Targeting of RANTES/CCL5 in Fungal Asthma.

DESCRIPTION (provided by applicant): Profound airway inflammation and airway remodeling accompanies responses to the fungus Aspergillus fumigatus, complicating asthma and cystic fibrosis. The introduction of A. fumigatus conidia into the airways of mice previously sensitized to A. fumigatus leads a fungal asthma-like disease characterized by elevated IgE and IgG1, and pulmonary expression of chemokines and Th2 cytokines. These events are also associated with a marked peribronchial accumulation of CD4+ T cells and eosinophils concomitant with marked airway hyperresponsiveness, goblet cell hyperplasia and peribronchial fibrosis. Previously, we have shown that the immunoneutralization of monocyte chemo-attractant protein-1 (MCP-1/CCL2) in A. fumigatus-sensitized mice challenged with conidia leads to aggressive fungal colonization due to a major compromise in the innate immune response. In contrast, we have observed that the immunoneutralization of regulated on T-cell activation, normal T cell expressed and secreted (RANTES/CCL5) does not impair the elimination of A. fumigatus and inhibits the development of chronic fungal asthma. Using this model, we will address the hypothesis that the selective targeting of RANTES/CCL5-responsive cells in the lung abolishes allergic effector and remodeling features of this model without compromising the necessary innate immune responses. This hypothesis will be addressed through the following three Specific Aims: 1) To determine the roles of RANTES/CCL5 in the pulmonary innate immune response against live A. fumigatus conidia. 2) To determine the mechanism through which iRANTES/CCL5 modulates the allergic effector responses mediated by T cells and eosinophils. 3) To determine the mechanism through which RANTES/CCL5 contributes to the persistent airway remodeling features such as goblet cell hyperplasia and peribronchial fibrosis that characterize chronic fungal asthma. These detailed studies are now possible because of the availability of novel chimeric protein that selectively targets RANTES/CCL5-responsive cells in the lung.